Uncovering the mechanisms of carrier-mediated WNT release and activity

Project Summary/Abstract
The Wnt signaling pathway is essential for embryogenesis and regeneration, and its mis-regulation is involved
in cancer and birth defects. The pathway is triggered by WNT ligands, a family of secreted proteins covalently
modified with palmitoleate. While the palmitoleate moiety is essential for WNT binding to Frizzled (FZD) receptors
and thus for signaling, it also makes WNTs stick strongly to membranes. This raised the fundamental question
of how WNTs are released from producing cells and spread to distant target cells.
In my postdoctoral work, I discovered that WNTs utilize a dedicated release pathway, forming soluble complexes
with carrier proteins that shield the palmitoleate from the extracellular environment. In Aim 1 of the present
proposal, I will extend these studies, to elucidate the unknown mechanism by which WNTs are transferred from
the essential membrane protein Wntless (WLS) to carriers; this will involve cryo-EM structure determination,
AlphaFold structural predictions, mutagenesis-guided experiments and mass spectrometry.
In recent work, I identified a glypican (GPC)-mediated pathway for the reception of WNT-carrier complexes by
target cells, which facilitates the transfer of WNTs to the FZD receptors. In Aim 2, I will determine the mechanism
by which WNT-carrier complexes are unpacked to initiate signaling. Additionally, I will explore how carriers
facilitate long-range WNT delivery to target cells, using advanced microscopy, and will investigate whether WNT-
FZD and WNT-GPC interactions exhibit specificity for canonical or non-canonical WNTs.
Given the absence of robust and quantitative reporter systems for non-canonical Wnt signaling (NWS), in Aim
3 I will first develop such reporters, based on NWS-specific genetic targets that I have identified and validated in
preliminary work. I will then use the reporter cells above together with genome-wide CRISPR screening, to
comprehensively discover novel components involved in NWS, which has remained poorly understood.
I anticipate that this work will significantly advance our understanding of Wnt signaling, by deciphering the
extracellular dynamics of WNT transfer between key binding partners. As these interactions occur extracellularly,
they present opportunities for the development of protein-based therapeutics that target aberrant Wnt signaling,
with greater specificity and fewer side effects compared to small molecules. To support this research, I have
assembled a comprehensive training plan, with advisory committee members who are experts in mass
spectrometry, structural biology, advanced microscopy, organoid culture, and antibody production. This proposal
provides a strong foundation for my long-term objective of establishing an independent research lab focused on
deciphering the molecular mechanisms of Wnt signaling and identifying novel therapeutic targets for correcting
pathological signaling.

Public health relevance
Project Narrative The Wnt signaling pathway governs critical processes in embryonic development, adult stem cell maintenance, regeneration, and the pathogenesis of various human cancers and birth defects. We have discovered that secreted FZD-related proteins (SFRP) and WNT inhibitory factor 1 (WIF1) function as WNT carriers, releasing lipidated WNTs and forming active soluble complexes, thus addressing the long-standing question of how WNTs spread in the aqueous environment during development. The proposed studies will use biochemistry, structural and cell biology to elucidate the mechanisms of carrier-mediated WNT release and activity, aiming to identify novel proteins regulating Wnt pathway output and discover new targets for inhibiting pathological Wnt signaling.